Core A: Administration

Core A Summary
The objectives of Core A (Administration) are to 1) manage the research program of the center to facilitate
overall research productivity by promoting communication and interaction among the investigators, graduate
students and post-doctoral fellows, cores, and the scientific advisory committee; 2) provide cost-effective
oversight of financial management and institutional communication to ensure timely responses to the needs of
each investigator, project, and core; and 3) leverage the resources of the center through additional support and
philanthropy. For Aim 1 (Management), Dr. Jack Fletcher, University of Houston, is the Core Director and
Principal Investigator of the Texas Center for Learning Disabilities (TCLD). The Co-PI of Core A and the TCLD
is Dr. Sharon Vaughn, University of Texas-Austin. Dr. Fletcher and Vaughn are experienced investigators and
research administrators and have worked together for the past 20 years on numerous research projects,
including the last 10 years as PI and Co-PI of the TCLD. Decision-making and the overview occurs through
monthly conference calls among the PI, Co-PI, and members of the Executive Committee. There are face-to-
face meetings of the Houston and Austin groups every 6 months and monthly conference calls focused on joint
efforts at data collection, risk mitigation, and paper productivity. We have plans in place for mitigation of issues
involving execution of the research program and risks to human participants. For Aim 2 (Efficiency and
Institutional Communication), we operate from our bases in the three university centers supporting the
TCLD. Efficient procedures are in place for creating accounts, establishing subcontracts, and managing post
award reconciliation and processing of orders and payments. Core A works closely with Core C (Data) and
Core D (Assessment and Recruitment) on ensuring cross-site quality control. There are established working
relations with the research divisions and IRBs at each institution. For Aim 3 (Leverage) we have secured
direct subsidies from our Universities and external support for center activities through the Texas Education
Agency (TEA) for our previous 10 year funding cycle and philanthropy through the Texas Consortium on High
Risk Children (Texas Consortium) and anticipate future support from these groups. Core A works closely with
Core B (Engagement) on dissemination and training, with an emphasis on promoting diversity and inclusion
with respect to the research and the researchers. Core A has effectively managed the TCLD the past 10
years, with a strong publication record, reliable financial management, established mechanisms for
publications, training and dissemination, and other accomplishments that make our Center efficient, effective,
synergistic, and cohesive.